Hormonal Contraceptives and Mental Health: Synthetic Hormone Influences on Fear Behavior, Neurocircuitry, and the Gut Microbiome

Project Summary/Abstract
Increasing evidence suggests that hormonal contraceptives (HCs) not only impact reproduction, but also
affect mental health. However, the biological mechanisms underpinning their psychiatric side effects remain
largely unknown. With HC use on the rise and fear-based mental illnesses twice as prevalent in women as they
are in men, there is a critical need to improve our understanding of HC effects on fear behavior mechanisms,
apply this knowledge to identify women at risk for psychiatric issues with HC use, and develop novel therapeutic
strategies to improve their treatment outcomes. Fear extinction processes serve as the basis for exposure therapy,
currently a primary treatment for fear-based mental illnesses such as PTSD and anxiety disorders. Unfortunately,
our existing understanding of HC effects on this process is conflicted, with some studies indicating fear extinction
impairments, while others find the opposite or no effects on fear extinction. These inconsistencies may be due to
a failure to distinguish different HC formulations based on their components of synthetic estrogens like ethinyl
estradiol (EE) vs. synthetic progestins like levonorgestrel (LNG). Preclinical models are essential to improving
our understanding as they facilitate the comparison of HC effects on behavior beyond what would be possible in
the clinical population. However, there is a lack of preclinical research examining HCs, especially broken down
into their individual components, in laboratory fear conditioning and extinction models. Another factor that may
contribute to the effects of HCs on fear is the gut microbiome, which is increasingly indicated in the modulation
of fear-related behaviors and has implications for mental health. The proposed project will use a translational
animal model of fear conditioning to address this critical gap. Our central hypothesis is that different HC
formulations will differentially impact fear extinction, with formulation-specific effects on fear network regions
and gut bacteria composition. We also predict that manipulating the gut microbiome during HC treatment will
alter specific formulation effects on fear conditioning. The rationale for the proposed research is that once HC
formulation-specific effects are identified, it may fill the gaps in our current understanding and contribute to
interventions that prevent or minimize negative HC side effects. This project has two specific aims. Aim 1 will
identify the differential effects of synthetic hormone formulations, EE, LNG, and EE+LNG on fear extinction
behavior and neurocircuitry and the gut microbiome in naturally cycling female rats. Aim 2 will investigate causal
relationships by manipulating the gut microbiome to determine which microbiota cause HC effects on fear
extinction. This study is significant because it will provide insight into potential target mechanisms underlying
HC-induced vulnerability or resilience to fear-related psychiatric disorders, a critical consideration for women’s
mental health and treatment. The proposed project is innovative because it will be the first to concurrently study
and delineate HC formulation-specific effects on fear learning and extinction, neurocircuitry, and the gut
microbiome. This is a novel approach that overcomes a critical methodological limitation in the current/existing
literature.

Public health relevance
Project Narrative Hormonal contraceptives (HCs) are used by more than 250 million women worldwide, yet their fear- and anxiety-related psychiatric side effects are not well understood due to conflicting findings. Establishing how different HC formulations impact fear behavior and neurocircuitry and how related systems, such as the gut microbiome, mediate these effects may enable us to reconcile the conflicting findings and identify those at risk of developing negative mental health outcomes. The proposed project aims to use an animal model of fear conditioning to identify novel target mechanisms for preventing or treating psychiatric side effects of HCs, providing insights that may enable women to make family planning decisions without compromising their mental health.